Novel Therapeutic Interventions for Patients with Alzheimer's Disease and Comorbid Dysphagia

PROJECT SUMMARY/ABSTRACT This career development proposal is designed to provide Nicole Rogus-Pulia, PhD, CCC-SLP, a Speech- Language Pathologist and an expert in dysphagia (swallowing dysfunction) at the University of Wisconsin- Madison School of Medicine and Public Health with the training required for success as an independent, clinician- scientist researching interventions to improve the care of dysphagia in patients with Alzheimer's Disease (AD). Dysphagia frequently develops in patients with AD and leads to serious health consequences, including decreased quality of life, caregiver burden, malnutrition, pneumonia, and mortality. Common treatments for dysphagia in patients with AD employ compensatory approaches that alter bolus flow to avoid aspiration (entrance of food or liquid into the airway). These approaches do not result in sustained improvements in swallowing physiology and often negatively affect quality of life. There are currently no effective treatments for dysphagia in patients with AD that can be practically applied or have lasting effects on the physiology of the swallow. The goal of Dr. Rogus-Pulia's proposed research is to develop effective dysphagia rehabilitative interventions for patients with AD at risk for adverse health consequences. Progressive-resistance lingual strengthening and saliva substitute are two interventions that have been shown in preliminary studies to positively influence swallowing function in older adults. This proposal will consist of a small, pilot randomized clinical trial to 1) determine the impact of two novel interventions on swallowing-related outcomes in patients with mild-moderate AD and 2) identify subgroups of patients most likely to benefit from these interventions. Patient- caregiver dyads will be randomized to lingual strengthening, saliva substitute use, a combination of the two, or usual care. Saliva and swallowing-related outcomes will be collected at baseline and following the 8 week intervention period. These data will support a larger, multi-site R01 funded study to determine effectiveness of these interventions for prevention of adverse health outcomes in patients with mild-moderate AD. As a junior faculty member at an institution with extensive infrastructure to support early stage investigators, Dr. Rogus- Pulia is in an ideal environment to complete the proposed research and pursue advanced training. Her career development plan includes both coursework and mentored training in the areas of 1) clinical trials design and analysis, 2) Alzheimer's disease clinical care and caregiving, 3) advanced statistical techniques, 4) implementation science, and 5) human factors and healthcare systems engineering. To ensure success, she has identified committed, expert mentors in these disciplines and secured protected time for this work. This award addresses a significant clinical dilemma and serious gap in AD research while affording the education and mentored research experience critical for Dr. Rogus-Pulia to lead an independent dysphagia research program.

Public health relevance
Project Narrative Patients with Alzheimer's Disease (AD) frequently suffer from dysphagia, or swallowing dysfunction, that can lead to serious health consequences, including impaired oral intake resulting in malnutrition, decreased quality of life, increased caregiver burden, and pneumonia. However, there are currently no effective treatments for dysphagia in patients with AD. The proposed work will test the impact of two interventions, tongue strengthening and saliva substitute use, on swallowing-related outcomes with a future goal to evaluate their ability to prevent adverse health outcomes in patients with AD.